Calcium modification of voltage gated sodium channels

PROJECT SUMMARY
Voltage-gated ion channels are essential for action potentials in excitable cells located throughout the body
(central nervous system, smooth muscle, heart and skeletal muscle). Loss of, improper, or untimely function,
can each cause or contribute to disease. Many individual point mutations in the genes of ion channel or
accessory proteins have been associated with disease, some of which can be life threatening. Many disease-
associated mutations are at or near accessory protein binding sites. Therefore, significant effort has been put
forth by many investigators to characterize mechanisms of ion channel gating modification.
It is well established that Ca2+ can alter ion channel function, and the Ca2+ sensing protein calmodulin
(CaM) has a prominent role in these processes. Structural investigations have identified many distinct CaM-ion
channel interactions; however, the posited physiological function and interpretation of this data is often
controversial. Early studies relied on measuring ion channel function in the absence or presence of Ca2+ and
this has generated seemingly disparate results. Subsequent investigation revealed the mechanism(s) of Ca2+-
driven modification are complex and can involve multiple accessory proteins.
I previously identified a high-affinity interaction between CaM and part of a voltage-gated sodium
channel that is directly responsible for inactivating conduction. I leveraged my in-depth structural
characterization to impair the CaM interaction without conferring additional modification to channel function.
This is a notable accomplishment given this part of the channel undergoes rapid conformational change during
each functional cycle. Because of this, I could for the first time clearly attribute modified sodium channel
function to reduced CaM binding. My data demonstrate that sodium channels with this reduced CaM
interaction require longer to recover from the inactivated state.
Considering my structure/function findings with literature suggests a paradigm of CaM Facilitated
Recovery from Inactivation (CFRI). As demonstrated in my papers and scientific data, CaM engages the
inactivation gate of several sodium channel isoforms with high affinity, suggesting a unique model of
regulation. My findings are in direct conflict with other reports that posit models of CaM Dependent Inactivation
(CDI) and [Ca2+] insensitivity. These opposing models arise from knowledge gaps regarding (i) the kinetic rates
of CaM interactions and (ii) the precise role of each CaM interaction in an excitable cell that contains oscillating
[Ca2+]. My proposal addresses these knowledge gaps by uniquely combining structural biology, stopped-flow
kinetics, and electrophysiology to dissect the roles of the CaM-ion channel interactions in excitable cells.
Importantly, we then leverage this knowledge to design custom small molecules (SAR by NMR approach) that
alter the kinetics of accessory protein interactions, with a goal of tuning channel gating. This work will test
models of Ca2+ modification of ion channel function, and explore novel strategies for treating channelopathies.

Public health relevance
PROJECT NARRATIVE Voltage gated sodium channels are essential for action potentials in excitable cells located throughout the body (central nervous system, smooth muscle, heart and skeletal muscle), and loss of, improper, or untimely function, can each cause or contribute to disease. There has been much controversy regarding the mechanism and interpretation of data for calcium modification of sodium channel gating due to: (1) the approaches used for investigation, and (2) knowledge gaps that arise from a lack of: (i) data describing the kinetic rate of the calmodulin interactions, and (ii) investigating calmodulin function in the presence of calcium transients. This proposal will uniquely combine structural biology, stopped-flow kinetics, and electrophysiology to dissect the precise roles of the calmodulin interactions in excitable cells, and it will then explore if we can alter the kinetics of these interactions with a small molecule probe; which could give rise to a novel treatment strategy for certain types of sodium channelopathies.